Noradrenergic mechanisms of IPF

ABSTRACT
The pulmonary fibrosis that accompanies many conditions is characterized by progressive scar formation in the
adult human lung. Regardless of the underlying disease state, the presence of this complication portends a
worse outcome that is curable only by lung transplantation. Proposed pathogenic mechanisms suggest a poorly
understood interaction between epithelial cells and fibroblasts that is orchestrated by microenvironmental cues.
Understanding these aspects in the fibrotic microenvironment is of particular importance in diseases such as
Idiopathic Pulmonary Fibrosis (IPF) where patients present with established and often progressive disease. As
a result, identification of intervenable processes that can be targeted for safe and effective therapies remains a
critical unmet need. It is therefore relevant that in a groundbreaking set of studies we have found that fibrotic
lungs are enriched for ectopically patterned adrenergic nerves, that these nerves drive fibrosis by releasing NA,
that NA driven fibrosis can be treated with α1 adrenoreceptor antagonists. This axis is active in IPF where lung
tissues are enriched for markers of adrenergic innervation and NA, and patients treated with α1 adrenoreceptor
antagonists experience improved clinical outcomes. We will now determine how NA accumulates in fibrotic
lungs and define its fibrogenic functions. For example, while we have found that adrenergic nerve remodeling
is stimulated by the dependence receptor deleted in colorectal carcinoma (DCC), the mechanism(s) of this
observation are unknown. We have found that fibrotic lung macrophages are deficient in NA catabolism
machinery, but whether they contribute to fibrosis via perturbed NA recycling has not been shown. Finally, we
have found an association between fibroblast proliferation and α1 adrenoreceptor subtype ADRA1D in fibrotic
mouse models and in human IPF that requires more study. This application will explore the mechanistic impact
and therapeutic potential of these findings using a unified vision and conceptual framework that will study how
nerve-derived NA accumulates in the lung and causes fibrosis. We propose an integrated project that pursues
three independent aims using a translational platform combining two animal models, manipulation of adrenergic
nerves, neuroengineering, cell specific knockout mice, genetic and pharmacologic gain and loss of function
approaches, ex vivo study of human cells and tissues, single cell sequencing, and microCT. The first aim will
probe whether adrenergic nerve remodeling and accumulation of fibrostimulatory NA requires expression of the
dependence receptor deleted in colorectal carcinoma (DCC) on adrenergic nerves in the lung. The second aim
will determine if perturbed NA recycling by macrophages exacerbates fibrosis in animal models and in human
cells and tissues. The third aim will use cell specific knockout mice and primary human cells and tissues to
determine wither NA-associated lung fibrosis requires ADRA1D-expressing fibroblasts. If successful, our project
will produce paradigm shifting results that will change the way we view – and treat – fibrosis in the adult lung.

Public health relevance
PROJECT NARRATIVE Noradrenergic mechanisms are increasingly linked to adult organ pathologies. We have recently detected this process in fibrotic rodent lung models and in samples from patients with Idiopathic Pulmonary Fibrosis. The current application explores the mechanistic and therapeutic ramifications of our discovery with the hope of gaining new insights into this challenging disease.